EFFECTS OF NICODERM ON FETAL AND MATERNAL SAFETY

This study has been completed. Our goal was to have 15 subjects complete the study. Seventeen subjects were enrolled. One subject did not complete. The data from one subject was excluded due to other factors. Data is currently being analyzed and several publications are planned. The investigators consulted with the GCRC biostatistician for analysis of this data.